Translational Studies on Electronic Cigarette-derived Oxidants and their Long-term Pulmonary Effects

Abstract
Cigarette smoke (CS) is a major source of reactive oxidants. Oxidative stress and damage resulting from
exposure to oxidants such as free radicals and aldehydes play critical roles in the development and
progression of most tobacco-caused diseases, including cancer and chronic obstructive pulmonary disease
(COPD). Using state-of-the-art high resolution analytical methods to detect and measure oxidants, we have
demonstrated that electronic cigarettes (EC) aerosols contain highly reactive free radicals and aldehydes;
albeit at levels which are typically 10- to 1000-fold lower than in cigarette smoke. We found that free radicals
were produced in all generations of EC products currently on the market, but that levels vary significantly by
EC product design and usage behaviors. Based on these studies and the known importance of oxidative
stress/damage in pulmonary diseases, our proposal focuses on toxicities caused by exposure to EC-derived
free radicals and aldehydes and their role in the development of COPD. Specifically, we hypothesize that 1)
EC aerosol exposure will be associated with negative long-term pulmonary health effects, albeit to a lesser
extent than combustible cigarette smoke exposure, and 2) switching from combustible cigarettes to EC will
lead to reductions in oxidant exposures and, thus, improved prognosis in COPD. In this proposal, we will utilize
a highly translational approach, conducting long-term in vivo exposure studies in a CS-induced COPD mouse
model and a pilot clinical intervention study of switching to EC in mild-moderate COPD smokers. The specific
objectives are to quantitate absolute levels of EC or CS oxidants at the point of exposure in the animal model
and to determine the relative impact of these oxidants through the examination of lung function (primary
endpoint). Pulmonary biomarkers of oxidative stress and inflammation will also be examined. The specific
aims have been designed to allow for a thorough evaluation of the long term health consequences of EC use in
naïve and CS exposed mice comparing effects of high vs. low oxidant products, and the impact of selective
filtration of oxidant-induced lung damage in the mouse (Aim 1); impact of switching from cigarette smoke
exposure to EC aerosols to mimic switching in humans (Aim 2); and translatability of laboratory findings in
smokers with mild-moderate COPD (Aim 3). Overall, these studies will significantly contribute to the field of
tobacco regulatory science by focusing on the toxicological importance of oxidant exposure from specific EC
devices. These data will be of particular value to the FDA for the development of regulatory policies aimed at
reducing harm imposed by tobacco products.

Public health relevance
Project Narrative Even though perceived as a less harmful alternative to conventional cigarettes, little is known about health consequences of long-term electronic cigarettes (ECs) use. Free radicals and aldehydes are oxidants, an important class of toxicant found in varying levels in EC aerosols generated from different products. Our proposal will examine the pulmonary toxicities associated with chronic EC use in comparison to combustible cigarettes in both laboratory animals and smokers with COPD.